Multidisciplinary K12 Urologic Research at Stanford (KUReS) Career Development Program

PROJECT SUMMARY / ABSTRACT
The overall objective of the Multidisciplinary K12 Urology Research at Stanford (KUReS) Career
Development Program is to develop the next generation of highly qualified MD, MD/PhD, and PhD scientists
to emerge as independent investigators capable of obtaining funding to support their research, leading their
area of research in benign urology, and ultimately bring meaningful impact to their field. During the program
period, Scholars will be given the training, courses, and guidance needed to achieve this goal; key to the
Program’s success will be the mentoring provided by our NIH-funded faculty preceptors. Twenty-eight Faculty
Preceptors drawn from 3 Schools, 6 Institutes/Centers and 16 Departments at Stanford, 8 Advisory Committee
members, and 6 Near-Peer Mentoring Committee members will collaborate to train junior physician scientists
and investigators (KUReS Scholars) to acquire the skills and experience needed to transition into productive,
independent physician scientists able to sustain viable careers and mentor future generations.
The KUReS Program bridges clinical care with excellence in basic, clinical and translational research to
address the national shortage of qualified investigators in benign urology. The Program includes a structured
training plan of sufficient duration to achieve independence, individualized didactic education based on skills,
competencies, and needs, extensive team-based mentoring, hands-on research, and protected time with
immersion in a vibrant research community. Stanford has robust mentoring systems, strong curriculum, and
solid infrastructure in place to prepare KUReS Scholars for research independence. Each Scholar will have a
multidisciplinary mentor team as well as access to a wealth of resources including the Stanford U54 O’Brien
Center, Stanford CTSA and NIDDK CAIRIBU network. We have an excellent pipeline of diverse Scholar
candidates and comprehensive collateral resources. Two KUReS Scholars will be supported each year of the
5-year Program. Duration of support for each Scholar will average 2-3 years. Leveraging on the expertise of
the Preceptors and Stanford’s outstanding infrastructure, Scholars will be recruited nationally to pursue one of
five research thematic areas: 1) Regenerative Medicine, Interstitial Cystitis/Bladder Pain Syndrome (IC/BPS),
and Voiding Dysfunction; 2) Urologic Omics and Lower Urinary Tract Symptoms (LUTS); 3) Urologic Imaging
and Engineering, 4) Urinary Stone Disease and Infections; and 5) LGBTQ+ Health and the Urinary Tract.
Scholars will develop essential skills and a portfolio of research projects to propel their transition to
independence. Research progress and career outcomes of Scholars are evaluated in an ongoing basis by
Faculty Preceptors, Program leadership and Advisory Committee members.

Public health relevance
PROJECT NARRATIVE The overall Multidisciplinary K12 Urology Research at Stanford (KUReS) Career Development Program is to develop the next generation of diverse, highly trained MD, MD/PhD, and PhD scientists to emerge as independent investigators capable of obtaining funding to support their research, leading their area of research in benign urology, and ultimately bring meaningful impact to their field. Having this program embedded in Stanford’s rich culture of innovation and collaboration provides an exceptional environment to empower the next generation of independent investigators who will advance reproductive health for all.